GlyCORE: Glycoscience Center of Research Excellence

Project Summary
The Glycoscience Center of Research Excellence (GlyCORE) was established in 2020 to develop a regional
hub of glycoscience excellence in the IDeA state-rich Mid-South region. Glycoscience is an essential and rapidly
emerging field of biomedical science and the challenging nature of glycoscience research requires tools and
expertise that are not commonly found in the biomedical research community. Moreover, the biomedical
community is rapidly growing to appreciate the essential role of carbohydrates, with investigators outside of the
dedicated glycoscience community facing challenging questions in glycoscience as part of the course of their
biomedical research. In Phase 1, GlyCORE established three Research Cores covering essential services to
support modern glycoscience: the Analytical and Biophysical Chemistry Research Core, the Imaging Research
Core, and the Computational Chemistry and Bioinformatics Research Core. GlyCORE also instituted a faculty
development program including recruitment of new glycoscience faculty, financial support of the investigators'
research efforts, a formal mentoring program, and priority subsidized access to University of Mississippi Core
facilities through both a Research Project program and a smaller Pilot Project Program. Finally, GlyCORE
initiated efforts to establish the University of Mississippi as a regional center for glycoscience in the Mid-South,
including hosting an annual Mid-South Glycoscience Meeting and a monthly Seminar Series to highlight the role
of glycoscience at the University of Mississippi and bringing in leaders in the glycoscience field. In Phase 2, we
will build upon our progress in Phase 1, refine our approach to improve metrics for success, and prepare for our
transition to long-term sustainability. We will expand the services offered by our Research Cores, including
expanding our workshop offerings to broaden our impact and user base. We will support four concurrent
Research Project Investigators throughout Phase 2 to improve the competitiveness of our researchers for major
extramural funding, as well as supporting a total of nine one-year Pilot Projects to develop research ideas from
their initial stages and aid in new faculty recruitment. In Phase 2, we will institute a cost-recovery model as part
of our transition to sustainability, using a voucher system to provide full Core support to our internal glycoscience
investigators. We will institute new programs to improve our investigator extramural funding success rate through
an enhanced external mentoring program and incorporation of professional external grant proposal review
services for current and previous Project Leaders. By the end of Phase 2, GlyCORE will be recognized as a
major destination for glycoscience in the Mid-South, with a core of faculty expertise and sustainable research
infrastructure necessary to support modern glycoscience.

Public health relevance
Project Narrative The University of Mississippi proposes to continue and expand the Glycoscience Center of Research Excellence (GlyCORE), a University-wide center to study how carbohydrates and carbohydrate-conjugates impact human health. GlyCORE will support and develop investigators in glycoscience through direct funding of selected research projects, establish mentors for early career investigators, support the recruitment of new faculty in glycoscience, and develop local and regional meetings for investigators to discuss their work. GlyCORE will also support three central research cores to ensure investigators in the Mid-South region have access to modern tools and methods necessary to support glycoscience.